Continuation of Type 1 Diabetes in Acute Pancreatitis Consortium – UF Health and AdventHealth Combined Clinical Center

The objective of this University of Florida/Advent Health proposal within the Type 1 Diabetes in Acute
Pancreatitis Consortium (T1DAPC) is to continue to establish and follow a longitudinal prospective cohort of
patients with acute and acute relapsing pancreatitis to investigate the incidence, pathophysiology,
mechanisms, environmental and biologic risk factors, and predictors of subsequent diabetes. The Diabetes
Institute at UF (UFDI) and the Advent Health Translational Research Institute have the resources and
capabilities required to continue to recruit these patients and perform comprehensive genetic, immunologic,
metabolic, histologic, and functional testing to dissect the various mechanisms underlying diabetes following
acute pancreatitis. Our proposal addresses key ongoing needs of the T1DAPC. 1) A platform for continuing to
recruit and follow large numbers of subjects with acute or acute relapsing pancreatitis. The combined volumes
of both health systems approach 2,000 patients admitted with acute pancreatitis yearly. The clinical expertise
and existing clinical research support structure is experienced and capable, and the two Institutes have the
scientific expertise to help define and support the whole variety of mechanistic studies that are ongoing; 2) The
development of an ancillary study (DREAM-ON) for which funding was obtained in an R01 (Rich Pratley, MD,
AdventHealth), and which is now launching. This will supplement the mechanistic studies of diabetes after
acute pancreatitis which are ongoing across the consortium; 3) A consortium opportunity to characterize the
mechanisms of diabetes across the spectrum of pancreatitis using both tissue and biologic specimens (our Aim
2). Collecting a bank of human pancreata from subjects with previous pancreatitis forms part of this proposal,
using the Network for Pancreatic Organ donors with Diabetes (nPOD), housed at the UF Diabetes Institute,
which collects and processes transplant-grade pancreata and other tissues from organ procurement
organizations (OPOs) across the U.S. and provides them for investigators around the world. We will leverage
this infrastructure, along with that of a large local OPO associated with AdventHealth, to obtain organs from
individuals with a history of acute pancreatitis. This will provide a unique resource for the T1DAPC, to
interrogate the mechanisms of diabetes in tissue, which is not readily accessible in living subjects. This can
provide a clinicopathologic correlation for the T1DAPC mechanistic studies. We believe the types of analyses
proposed will be necessary for the work of the T1DAPC, and we are able to fully support these aims or related
aims selected by the T1DAPC.

Public health relevance
Acute pancreatitis is common and increasing in both incidence and prevalence in the United States, with risk of subsequently developing exocrine insufficiency and/or diabetes approaching 30%. Hence, efforts to understand the mechanisms, risk factors, and predictors of diabetes following acute pancreatitis are of significant public health importance to facilitate the development of strategies for early detection, prevention, and effective management. Through the framework provided by the Type 1 Diabetes Acute Pancreatitis Consortium (T1DAPC), the combined University of Florida and AdventHealth team will serve as a high-volume center contributing to patient enrollment and collection of biological samples for mechanistic and clinical studies to characterize diabetes pathogenesis following acute pancreatitis, ultimately in support of future efforts to identify accurate biomarkers and more effective therapies.